High Performance Computing Instrumentation for the Yale Center for Genome Analysis

The advent of next-generation sequencing (NGS) is revolutionizing biology and medicine and is rapidly
becoming a standard tool for investigation. Recognizing the tremendous potential of NGS, Yale University
establish the Yale Center for Genome Analysis (YCGA) in 2009. YCGA has led the development of a new
genome center model, focusing on a centralized facility with the highest standards of innovation, data production
and analysis, but which is open access to the community rather than having projects selected by an oversight
group. This scalable model has provided broad access to NGS, which has spurred innovation and eliminated
barriers to experimentation by new users. By virtue of its substantial contribution to technology development for
data production and analysis, accompanied by high profile scientific discoveries and success in competing for
NIH funding, YCGA has emerged as one of the leading genome centers in the country.
High-performance computation is indispensable for NGS operation. YCGA produces an average of more
than 30 terabases of sequence data per month, necessitating infrastructure for data storage, analysis and
interpretation. YCGA’s current dedicated HPC instrumentation has served more than 1,000 users from 327
institutions/departments as well as many non-Yale investigators, and is making an enormous contribution to
biomedicine (since 2015 published >500 research articles including, >70 publications in Science, Nature, Cell,
N Engl J Med) reporting new genes contributing to autism, cardiovascular disease, cancer, and congenital
diseases of the heart and brain, as well as fundamental advances in understanding of enhancer function,
mechanisms of microRNA formation, and mechanisms of evolutionary change. YCGA's dedicated compute
cluster and storage is predominantly 6 years old and near the end of its productive life. This architecture must
be replaced and upgraded if YCGA is to continue to serve its users. The requested HPC instrumentation will
increase computational capacity to match growing demand, will greatly improve data storage and networking,
and will reduce the power and cooling requirements.
The strengths of this proposal include; (1) an efficient and effective centralized facility serving an
extremely diverse, large and productive mostly NIH funded investigator user base; (2) the demonstrated ability
of YCGA to effectively integrate cutting edge data production and analysis for the benefit of hundreds of NIH
funded Yale and non-Yale researchers, (3) and the extensive infrastructure and expertise that is available to
bring the requested instrumentation online and to oversee its continuous use.
Yale University has made a major investment in capital and institutional talent to build a first-rate
infrastructure that has proven highly successful. The requested instrumentation will be highly leveraged upon
this existing infrastructure ensuring that it will be of high value and broad impact on NIH supported biomedical
and basic research within and beyond the Yale community.

Public health relevance
Project Narrative If this grant is funded, the requested instrumentation would replace and upgrade existing equipment nearing obsolescence in the Yale Center for Genomic Analysis HPC resource, allowing it to continue to provide biomedical researchers with a state of the art computing facility for the analysis of their next-generation sequencing data. Over the last 3 years, YCGA’s HPC resource has served over 200 researchers from approximately 61 separate research groups. Looking forward, the results of the proposed research would make a very substantial contribution to biomedical research that would extend to and increase our knowledge of development, evolution, epigenetics, hematopoiesis, infectious diseases such as HIV and sleeping sickness, and non-infectious diseases such as autism, hypertension, cancer, diabetes, renal diseases, asthma, chronic stress, developmental delays, coronary artery disease, drug addiction, dyslexia, and glaucoma.